Visual system and cognitive biology in normal animals versus in an animal model of Alzheimer's disease with or without diabetes treated with solo or dual inflammasome inhibitors

ABSTRACT
Alzheimer’s disease (AD) is a progressive neurodegeneration that accounts for the majority of dementia
worldwide. In addition to cognitive deficits, visual dysfunction is also common in AD and may be due to pathology
in the retina. Diabetes mellitus (DM), the metabolic syndrome responsible for diabetic retinopathy, is
characterized by hyperglycemia, hyperinsulinemia, and insulin resistance. DM has been identified as a significant
risk factor and comorbidity for AD in epidemiological studies and clinical trials. We recently identified a novel
dual NLRP3-NLRC4 inflammasome that may contribute to neurologic pathology. In this study, we will achieve
complementary goals of evaluating the consequences of AD complicated by DM on cognition, vision, and
molecular pathological hallmarks. In addition, using preclinical small molecule inhibitors, we will determine the
efficacy of dual NLRP3-NLRC4 inflammasome inhibition on visual and cognitive readouts in AD models in the
presence or absence of bona fide DM. We propose to address this gap by testing solo and dual inflammasome
inhibitors in models of combined DM/AD. We hypothesize that dual inflammasome inhibition is superior to solo
inflammasome inhibition in preventing visual dysfunction and cognitive impairment in DM/AD mice. Together
these studies will elucidate whether combined DM/AD exacerbates retinal and brain pathologies, and identify a
potential therapeutic strategy to address these complex and prevalent conditions.

Public health relevance
NARRATIVE Diabetes mellitus (DM) is a complicating factor in Alzheimer’s disease (AD). We will determine whether combining models of DM and AD exacerbates key pathological outcomes in vision and cognition. In addition, we will test the efficacy of preclinical anti-inflammatory compounds in alleviating these pathologies.